Safety and analgesic efficacy of marine lipid precursors of specialized pro-resolving mediators in adults with chronic temporomandibular pain.

The inflammation-resolving, analgesic, and anxiolytic properties of lipid derivatives of marine omega-3 (n-3)
fatty acids offer a novel therapeutic approach for painful temporomandibular disorder (TMD). We used ultra-
high performance liquid chromatography (UHPLC) tandem mass spectrometry methods to quantify fatty acids
and their lipid derivatives in 605 adults. We reported that low levels of n-3 fatty acids were associated with
greater odds of chronic TMD pain, hyperalgesia, psychological distress, sleep disturbance, and greater pain
intensity. While promising, these observational study findings lack the rigor of a randomized controlled trial.
Design: This phase 2b, proof-of-concept, triple-masked, randomized, placebo-controlled, parallel-group clinical
trial will evaluate the safety and analgesic efficacy of a marine oil supplement in adults with chronic TMD
myalgia and/or arthralgia. The intervention is a dietary supplement of active fractionated n-3 marine lipid
concentrate standardized to 18-HEPE, 14-HDHA and 17-HDHA, which are precursors to specialized
proresolving mediators (SPMs) that regulate multiple pain-related biochemical pathways. The primary endpoint
is postbaseline change in pain intensity recorded on a 0-100 numeric rating scale. The sample size of 100
provides 80% power to detect a “moderately important” decrease of 34% in pain intensity in the intervention
group compared to a “minimally important” decrease of 11% in the placebo group.
UG3 planning phase: We will obtain regulatory approvals and develop study documents and data systems
needed to implement the trail, optimize recruitment with CTSA resources, and refine UHPLC tandem mass
spectrometry analysis for targeted profiling of 67 bioactive oxylipins and SPMs in erythrocytes and plasma.
UH3 implementation phase: UH3 Aim 1 will quantify safety by comparing the rate of adverse events between
study arms. UH3 Aim 2 will compute change in pain intensity in each treatment arm and estimate efficacy
using two approaches in intention-to-treat analyses: (i) a linear mixed model will estimate treatment-group
difference in mean post-baseline change in pain intensity; and (ii) a log binomial model will estimate treatment-
group difference in the proportion of subjects whose mean pain intensity reduces by at least 30%. UH3 Aim 3
will evaluate reductions in hyperalgesia, psychosocial distress, sleep disturbance, and biochemical changes.
We anticipate that the intervention will increase concentrations of proresolving, antinociceptive and anxiolytic
oxylipins, and decrease omega-6 derivatives, and that these changes will correlate with changes in the clinical
endpoints. UH4 Aim 4 will use causal mediation methods to determine if a therapeutic effect (or non-effect) is
due to change (or lack of change) in nociception, psychological distress, sleep disturbance, or headache.
Impact: Ten million U.S. adults have chronic TMD pain. This clinical trial may lead to a novel therapeutic
approach for chronic TMD pain that resolves inflammation and reduces pain, sleep disturbance and
psychological distress while overcoming the efficacy and tolerability limitations of current therapies.

Public health relevance
Project Narrative Chronic temporomandibular disorder (TMD) pain often overlaps with hyperalgesia, psychological distress, sleep disturbance, and pain in other body areas. A risk factor for each of these disorders is a low level of omega-3 fatty acids and their lipid derivatives known as specialized proresolving mediators (SPM) that have potent proresolving, analgesic and anxiolytic properties. This randomized controlled trial will determine whether a dietary supplement of long-chain omega-3 fatty acids enriched with SPM metabolic precursors safely reduces TMD pain and these overlapping disorders in adults with chronic TMD myalgia and/or arthralgia.